Resource Core B - Modeling of skin disease for mechanistic analysis and therapeutic discovery

Summary – Resource Core B
Many technical, logistical and cost barriers hinder efficient and feasible access to high-end experimental
approaches in skin research. Efforts by Core B, “Modeling of skin disease for mechanistic analysis and
therapeutic discovery” will systematically overcome these barriers for skin researchers by facilitating access to
human skin samples, harnessing our expertise in generating and analyzing sophisticated mouse genetic and
human iPSC-derived models of skin disease, and providing a streamlined interface with Core C for genomics
and transcriptional analyses. In parallel, the entry barriers to skin biology and diseases research will be
lowered by providing Pilot Grants to junior investigators and researchers newly entering the skin biology and
diseases field, and the costs of high-end technologies will be defrayed by User Scholarships. Core B will offer
users specialized technical, clinical and scientific know-how and services in advanced skin research as well as
critical research infrastructure by providing A) clinical and histopathological expertise for easy retrieval of
normal and diseased human skin and access to efficient multiplexed skin marker analysis for physiological and
skin disease studies; B) scientific expertise and service for physiological studies of fundamental skin functions
with advanced genetic mouse models and cell isolation and imaging technologies; and C) scientific expertise
and service for human skin disease modeling with patient-derived iPSC technology and with CRISPR-based
gene editing and expression manipulation for mechanistic analysis and therapeutic target discovery. These
goals will specifically be achieved by 1) providing samples from our vast collection of archived normal and
diseased human skin; 2) facilitating access to de-identified fresh human skin samples; 3) advanced multiplexed
immunohistochemical imaging of marker proteins; 4) aiding in the generation of state-of-the-art genetic mouse
models for skin functional studies; 5) providing training in refined isolation technologies for specific skin cell
populations; 5) providing training for advanced live imaging in vitro and in vivo; 6) generating patient iPSCs and
differentiating them to skin cells to model human skin disease; and 7) studying candidate skin disease genes
by generating isogenic mutant and control iPSC-derived skin cells and through Cas9-based gene expression
manipulation.